The Function of Neural Activity in Developing Retina

PROJECT SUMMARY/ABSTRACT
Spontaneous activity is a hallmark of developing neural systems. Prior to the maturation of vision, immature
retinal neurons spontaneously generate correlated activity. This activity propagates in the form of waves of action
potentials that sweep across the retinal ganglion cell layer. Retinal waves persist from embryonic day 16 through
two weeks after birth, a developmental period when functional circuits within the retina are emerging and retinal
projections to the brain are undergoing a tremendous amount of refinement. Here we explore three Aims regarding
mechanisms underlying the function of retinal waves.
In Aim 1, we focus on understanding the circuits that mediate embryonic retinal waves. At this age, the retina is
comprised of retinal ganglion cells, a few amacrine cells, and an extensive neuroblastic layer in which the other
cell types are differentiating. Despite the lack of mature circuit elements, retinal waves are robust. Here we test
hypotheses regarding the relative role of gap junction coupling and synaptic transmission in mediating these
waves.
In Aim 2 we focus on second postnatal week when retinal waves exhibit a profound propagation bias. During this
time period, the majority of waves travel in the nasal direction, a firing pattern which mimics optic flow induced
by forward motion. Here we explore the hypothesis that this asymmetry in propagating activity is due to
asymmetric connectivity between a GABAergic interneurons that are well integrated into wave generating
circuits.
Finally, in Aim 3 we investigate the role of retinal waves and visual stimulation of light-sensitive retinal ganglion
cells in the release of dopamine in the developing retina. Though dopamine plays a key role in several
developmental processes, what controls release is unknown. We will employ a novel imaging method that allows
for measuring phasic dopamine release in parallel with calcium transients. Using this method, we will explore the
relative role of retinal waves and light stimulation in mediating dopamine release during development.”

Public health relevance
PROJECT NARRATIVE Retinal waves are highly correlated spontaneous firing patterns detected in the developing retina prior to maturation of visual responses, and they provide a critical source of activity to drive the refinement of connections throughout the developing visual system. Retinal waves are a robust phenomenon detected in many vertebrate species, and they persist through the changing circuits of the developing retina. Our work will determine the cellular and synaptic basis of these waves with the goal of understanding their spatiotemporal features that are critical for development of visual circuits. Moreover, we will determine the relative contribution of waves and light-activation of intrinsically photosensitive retinal ganglion cells in the regulation of dopamine levels, a neuromodulator critical for development of the retina and surrounding tissues. This work with will contribute to a detailed understanding of the organizing principles that govern the normal development of retinal circuits, contributing to our understanding the origin of some neurological birth defects.